Optimize Formulation of VSA Adjuvant

The contract supports the development of a saponin as a vaccine adjuvant. The adjuvant development activities are being conducted within the context of vaccines to protect against SARS-CoV-2 and pneumococcal infection.